New class of PBP inhibitors to address PBP2-mediated resistance in Neisseria gonorrhoeae

PROJECT SUMMARY
Multidrug resistant-gonorrhea is a serious global health threat. Penicillin Binding Protein-targeting β-lactams
have long been the front line therapeutic option for gonorrhea, but are now in serious jeopardy. Resistance to
the last remaining front line β-lactams, the extended spectrum cephalosporins, has steadily increased over the
past decades resulting in the CDC eliminating cefixime as a therapeutic option in 2012. Now only ceftriaxone
remains, but a series of resistant clinical isolates exhibiting PBP2-target based resistance have emerged in the
past decade, forecasting its imminent failure. As few clinical development candidates addressing MDR-
gonorrhea are in the drug development pipeline, and vaccine development is unlikely to be a solution due to high
antigenic variability in clinical isolates, there is an urgent need for new therapeutic options. A new chemical
series maintaining PBP target inhibition represents a promising strategy, enabling new combination therapies to
minimize further evolution of resistance. VenatoRx has identified a novel chemical series of reversible covalent
non-β-lactam Penicillin Binding Protein inhibitors impervious to the action of β-lactamases that are being
optimized to address altered PBP2 targets responsible for ESC-resistance in Neisseria gonorrhoeae. Significant
strides in microbiological activity have been achieved with the lead compound VNRX-6355 in MDR-gonorrhea
isolates including a mosaic PBP2-producing H041 clinical isolate. Improved binding to altered PBP2 variants by
VNRX-6355 has provided a >128-fold improvement in microbiological activity in H041 over initial hit compounds
in the series (shift in MIC from >512 mg/L to 4 mg/L) and is only 8-fold away from our MIC target to obtain an
MIC90 of ≤0.5 mg/L. These compounds are highly selective, rapidly bactericidal and efficacious in a murine
septicemia model of E. coli infection. The goal of this proposal is to select a potent preclinical candidate
addressing PBP2 target variants in ESC-resistant gonorrhea, confirm favorable PK properties for intramuscular
administration, select the first preclinical development candidate, perform preclinical IND-enabling studies and
file an IND with the US FDA. Ultimately this approach is intended to be a long term strategy to safeguard PBP-
targeting in gonorrhea treatment by preventing the expansion of β-lactamases in Neisseria gonorrhoeae that
would inevitably evolve from more effective targeting of PBP2 variants by current or newly optimized β-lactam-
based strategies.

Public health relevance
PROJECT NARRATIVE The PBP targeting β-lactams have been a mainstay therapeutic option for gonorrhea for the past 50 years, but now ceftriaxone, the last line outpatient β-lactam option is under intense pressure due to emerging target-based resistance. This application focuses on the development of a new intramuscular therapeutic Penicillin Binding Protein inhibitor to address altered PBP2 drug targets responsible for extended spectrum cephalosporin (ESC) resistance in Neisseria gonorrhoeae.